AWARE Project 2: Alcohol use and geriatric syndromes among specific minoritized groups living in socioeconomic disadvantage

AWARE PROJECT 2 (GERIATRIC SYNDROMES)
Alcohol use is common among people with HIV (PWH) and can exacerbate HIV associated inflammaging
(chronic inflammation and immune dysfunction), increasing the risk of debilitating geriatric syndromes among
PWH. The etiology of both HIV and alcohol use underscores the important role of syndemic social risk factors
in determining health outcomes - particularly for those living in socio-economically disadvantaged communities.
Best practices suggest that studies aimed at understanding adverse health outcomes born from syndemic risks
should center on communities of interest and investigate structural determinants that shape their experiences.
Using best practices, we propose to understand associations between alcohol use and key geriatric syndrome
outcomes for people with HIV, and to investigate whether neighborhood socioeconomic disadvantage—a
composite structural determinant of health representing multiple facets of access to resources—moderates
these relationships. Specifically, we will determine associations of unhealthy alcohol use with falls, fractures,
delirium, dementia, physiologic frailty and mortality (Aims 1 and 2) among people with HIV, and evaluate
whether associations in Aims 1 and 2 vary based on neighborhood socioeconomic disadvantage (Aim 3). We
will evaluate all aims in the Veterans Aging Cohort Study (VACS), both overall and secondarily within and
between subgroups. We hypothesize that alcohol use has greater impact on geriatric syndromes among
people with HIV, with greater risk among those living in areas with greater socioeconomic disadvantage. Our
findings will also be independently validated in two outside cohorts. This research will be conducted by a team
with a strong collaborative history with expertise in health services research, HIV, addiction medicine, geriatric
syndromes, and alcohol research. This proposal is innovative given its focus on understanding the role that
multilevel, intersecting factors have on geriatric syndromes among PWH within key understudied and
disproportionately impacted subgroups. These data have potential to be of high impact as they will identify the
role of potentially modifiable targets on geriatric syndromes and generate data on who to prioritize for practice
and policy intervention.